Effects of bilingual language control on speaking

PROJECT SUMMARY/ABSTRACT
Bilingualism brings fascinating cognitive and neural adaptations, thought to be brought about by the
daily practice of language control, a set of mental processes ensuring the use of the appropriate language(s).
The highest control demands are imposed by a dual-language context (speaking two languages in close
succession but to different individuals; Adaptive Control Hypothesis, Abutalebi & Green, 2013). To understand
language control and bilingual adaptations, it is key to understand how language control unfolds during
naturalistic language production and how it interacts with the speaking process. However, this is currently
unknown – existing evidence comes from constrained lab tasks, mostly involving saying single words.
The current study will address this gap by determining the effects of language control during
naturalistic language production in a dual language context. Spanish-English bilinguals dominant in
English will describe the content of lab-created short videos. In a Two-language session, they will speak
Language A before and after Language B. In a Single-language session, they will speak only Language A,
before and after a distractor task. In Experiments 1 and 3, Language A will be the non-dominant language, and
in Experiments 2 and 4, Language A will be the dominant language. The proposed research will determine the
effects and added cognitive load of bilingual language control on speaking quality and fluency, to test
predictions of language control theories. (1) Experiments 1-2 will establish the effects of language control on
predetermined speech characteristics. Both theory and evidence predict slower speech rate, more pauses,
fewer words, fewer unique words and higher-frequency words during both application and recovery from
inhibition. A novel hypothesis is tested that adverse effects on some of these characteristics help others stay
unaffected. (2) Experiments 3-4 will establish the added cognitive load of language control by measuring the
rates of concurrent tapping of a trained sequence by one group of bilinguals. Slower tapping will index more
effort. Language control theories predict that the application of inhibition is cognitively effortful. (3) The time-
course of language control will be examined by analyzing changes of tapping rates across time, to further
constrain language control theories.
The proposed research will determine the effects of bilingual production dynamics on naturalistic
language production, and will increase understanding of human cognition. It has major clinical implications. It
will help determine criteria to distinguish healthy from impaired speech, establish potentially more cognitively
effortful contexts of language use, and inform research aimed at understanding impaired bilingual speech.
Analyses of speech characteristics could aid early diagnosis of incurable neurodegenerative diseases such as
Alzheimer's disease (Ostrand & Gunstad, 2020). Implementation of the proposed research will also prepare
underserved students for research careers.

Public health relevance
PROJECT NARRATIVE The proposed behavioral research will determine the theoretically predicted effects of speaking one followed by another language for bilingual individuals, which could include speaking more slowly, making more pauses, using fewer (unique) words and increased effort. Such effects are important to establish because they would help distinguish healthy language use from language impairments and better understand impaired bilingual speech, which could aid early diagnosis. The training of Hispanic/LatinX student research assistants in Psychology will increase diversity in research and help prepare disadvantaged students for future research careers.